Scope and mechanism of coordinated alternative splicing and alternative polyadenylation

Project Summary:
In metazoan animals there is an incredible diversity of alternative transcript isoforms generated from
genes. The alternative parts making up a mature full length mRNA include alternatively selected transcription
start sites, 5′ UTRs, protein-coding exons, 3′ UTRs, and polyA sites. We have gained incredible insights into the
cellular conditions and protein factors that regulate these alternative choices, but these regulatory events are
usually studied in isolation. What is far less understood is how these alternative choices are coordinated together.
This is partly because of limitations in the molecular techniques to study full length transcript isoforms. Long-
read RNA sequencing technologies present a new tool to study how the alternative parts of a transcript come
together.
The majority of genes in metazoans undergo alternative polyadenylation to produce alternative length 3′
UTR isoforms. Long 3′ UTR isoforms are enriched in neural tissues, whereas short 3′ UTR isoforms are enriched
in proliferating cells and in testis. In Drosophila, we recently identified that long 3′ UTR biogenesis and alternative
splicing of the Dscam1 gene are co-regulated by the RNA-binding protein Elav in neurons. We found that these
events are required for neuronal function in Drosophila. Our preliminary analysis shows that this coupling of
alternative splicing changes to alternative 3′ UTR selection affects other genes in Drosophila.
How widespread is the coupling of alternative exon selection to alternative 3′ end formation? Due to
limitations in short-read RNA sequencing technologies, the genome-wide scope of such coupling events is
unknown. We will employ new long read RNA-sequencing technologies to uncover 3′ UTR-coupled alternative
splicing events genome-wide that are regulated by RNA-binding proteins such as Elav.
What is the mechanism that coordinates 3′ UTR biogenesis with alternative splicing? In addition to co-
regulation of alternative splicing and alternative polyadenylation of Dscam1 by Elav, we found that the presence
of the Dscam1 long 3′ UTR was necessary for Elav-regulated alternative splicing. What is the nature of this “at
a distance” regulatory event? A possible mechanistic explanation involves looping of the pre-mRNA such that
the long 3′ UTR interacts with upstream splice sites to deliver RNA-binding proteins. We will test this pre-mRNA
looping model through mapping RNA-RNA interactions, in vivo mini-gene reporter analyses, targeted screens,
and RNA-affinity chromatography. This mechanistic investigation will be expanded to other genes and cell types.
The proposed research program will identify the rules governing coordinated alternative splicing and
alternative polyadenylation. The coordination of RNA processing steps to produce mRNAs with specific protein-
coding and regulatory properties is likely important for many cell types and eukaryotic organisms, including
humans.

Public health relevance
Project Narrative: Alternative 3' UTR usage and alternative splicing occurs for the vast majority of genes in metazoan animals, including humans. The proposed research program will investigate how these two events in RNA biogenesis are coordinated to generate mRNA transcripts with specific combinations of protein-coding exons and 3' UTR sequences. !